Cerebellum's Role in Perceptual Timing Behavior

The perception of time, and more generally, the use of temporal information, is an integral part of our everyday
experience. It is thus an essential capability of the brain. Despite its importance, the network underlying the
ability to time events on relatively short time scales (i.e., seconds or less) is not fully known. We believe the
cerebellum is a strong candidate for being a member of this network for several reasons. It has a well-
established role in timing motor responses, and the near constancy of its intrinsic circuitry suggests that it
should perform similar computations for both its motor and non-motor functions. Furthermore, our preliminary
data from a perceptual timing task provide evidence that the lateral cerebellum plays a role in perceiving the
duration of sensory events. Thus, we propose to investigate the cerebellum's role in time perception using
electrophysiological and optogenetic techniques in combination with a standard (temporal bisection) and a
novel (trianchor bisection) interval timing task. In these tasks, rats discriminate auditory stimuli based on their
duration for a reward. In Aim I, we will selectively manipulate the activity of identified cerebellar neuronal
populations using optogenetic tools in order to provide evidence of a causal link between the activity of lateral
cerebellar neurons and the perceived duration of the sensory stimuli. We will test how task-related information
is encoded by specific classes of cerebellar nuclear neurons, including cerebellar nuclear cells that project to
the thalamus and cerebellar nuclear cells that receive input from crus 1 of the cerebellar cortex, a region
implicated in cognitive functions and that is interconnected with prefrontal cortical areas. Various optogenetic
stimulation patterns will be tested for their effects on timing behavior in the temporal bisection tasks to
investigate which spike train parameters may be used to encode task-related information. In Aim 2, we will
record from cerebellar neurons and determine the correlates of their activity with the animal's performance on
the temporal bisection task. We will also investigate the possibility of other behavioral correlates of lateral
cerebellar activity, and determine whether temporal and non-temporal information is encoded by the same or
separate neuronal populations. The information gained through these experiments will improve our
understanding of how the cerebellum encodes information about time perception and how it interacts with other
brain regions involved in this process. Such knowledge should also improve our understanding of how
dysfunction of the cerebellum contributes to a variety of neurological and psychiatric disorders.

Public health relevance
The cerebellum is now recognized as essential for a wide range of cognitive and affective functions in addition to having a central role in motor coordination, and correspondingly, evidence now indicates that cerebellar dysfunction may contribute to various cognitive and psychiatric disorders, including fetal alcohol syndrome, schizophrenia, autism, and fragile X syndrome. The cerebellum is thought to provide timing information for normal brain function, and abnormal motor and perceptual timing occurs in many of these disorders. Thus, investigating the role of the cerebellum in timing tasks, the overall goal of this proposal, will increase our understanding of the cerebellum's role in cognition, and how cerebellar dysfunction contributes to neurologic and psychiatric disorders.